Decreased pacemaker activity in aged sinoatrial node

How does the General Theory of Cardiac Chronotropy and Inotropy Apply to Aging? Both our earlier and very recent studies have contributed seminal perspectives toward understanding age-associated deterioration of both cardiac contractility and heart rate in both humans, and in animal models. Our studies of healthy participants in the Baltimore Longitudinal Study of Aging (BLSA) demonstrated substantial age-associated changes in the ability to increase heart rate and reduce end systolic volume in response to graded exercise stress. (Of note, only the latter, but not the former, can be improved by physical conditioning.) We subsequently demonstrated that deficits both in contractility and heart rate in humans are due, in part, to reduced -AR stimulation response of cAMP-PKA. 1. Contractility In isolated rat cardiac ventricular muscle, we had directly demonstrated a reduction in the Ca2+ cycling and contractile response to -AR stimulation. The relaxation time of the Ca2+ transient and contraction in the absence of -AR stimulation were prolonged, that we traced to a reduced expression of SERCA2. The AP was also markedly prolonged, due to age-associated changes in L-type Ca2+ and K+ currents. In single VM, in addition to numerous properties of surface membrane ion channels, we documented an age-associated reduction in the VM Ca2+ clock, manifest as a prolonged time for restitution of the excitation- Ca2+ release-contraction coupling process, was due to a prolonged restitution time for SR Ca2+ release via RyRs in response to activation by an L-type Ca2+ current. We also showed that SR Ca2+ loading and the amplitude of the Ca2+ transient were preserved in myocytes from the old heart, by virtue of the prolonged AP. 2. Heart rate Our discovery of heart rate regulation by a coupled-clock system in rabbit SANC enabled progress, finally (after 25 years), on the elucidation of potential cellular mechanisms of the age-associated reduction in chronotropic reserve. Specifically, our conceptual breakthrough that regulation of basal pacemaker cell automaticity requires Ca-PKA-CaMKII signaling regulated by PDE and phosphatase activities, and that stimulation of receptors merely extended this regulation, led us to hypothesize that mechanisms involved in the deterioration of mechanisms that regulate of intrinsic heart rate that accompanies advancing age and that those regulating heart rate reserve may involve a slowing of the Ca2+ clock of SANC and linked, in some respects, at least, to the age-associated deterioration of mechanisms that regulate Ca2+ cycling and contractility in VM. Phospholamban (PLB) phosphorylation at Ser16 (PLB/total PLB) immunolabeling in control did not differ with age, increased 2.20.2 fold after incubation with 10 M IBMX in young, but did not increase in old SANC. The intrinsic SR Ca2+ cycling and its response to PDE inhibition decline with aging, and are candidate mechanisms to explain, in part at least, the age-associated decrease in IHR. We had failed for five years in our attempts to isolate single mouse sinoatrial node cells that exhibited stable normal automaticity. Recently, we have met with some success. Our initial results indicate that: the spontaneous AP firing rate of single SANC declines with age;the maximum RyR Ca release flux in response to an AP (indexed as d Ca/dt max) declines with age;and the kinetics of relaxation of the Ca2+ transient become reduced with age. Our results suggest that the intrinsic cAMP-PKA-Ca2+ signaling is deficient in the aged mice. This deficiency may result from: 1.)reduced amount or function of Ca2+ cycling proteins e.g. SR Ca2+ pump, phospholamban (PLB), RyRs. and/or 2.) reduced phosphorylation of Ca2+ cycling proteins e.g.PLB, in response to an increase in cAMP-mediated-PKA dependent phosphorylation. 3.) These deficiencies may explain why the aged heart cannot beat as fast as the young heart. Future plans are: 1) to employ western blotting in cells from young and old SANs to measure Ca2+ cycling protein density;2) to directly measure the downstream signaling of cAMP-PKA- Ca2+ pathway i.e. PKA-dependent protein phosphorylation and phosphatase activity.